Exploring the Molecular Physiology of Atrial Fibrillation

Atrial fibrillation (AF) is the most common cardiac arrhythmia and accounts for substantial morbidity and mortality. Despite decades of research current treatments remain only partially effective, or in the case of ablation, invasive, costly and not effective in some patients. Development of novel, effective and safe therapy for AF has been hampered by the lack of animal models that reflect AF in humans. While some large animal models exhibit aspects of human AF it is difficult to test and develop novel small molecule therapies for AF in these costly and limited models. Ideally, a small animal model that faithfully phenocopies human AF would be an invaluable tool for both understanding the molecular physiology of AF and potentially for identifying and testing novel small molecule therapeutics. Indeed, murine models have proved invaluable in the development of novel therapeutics for cancer, diabetes and obesity. The lack of a mouse model for AF is a barrier to research in this important disease. To address this gap we created doxycycline-inducible transgenic (TG) mice with a mutation (F1759A) of the local anesthetic binding site in human SCN5A, the cardiac NaV1.5 channel gene. Fortuitously these mice exhibit modest atrial enlargement and fibrosis, mitochondrial dysmorphology, frequent, sustained episodes of spontaneous AF, and non-sustained polymorphic ventricular tachycardia, observed as early as 5 weeks of age in the absence of doxycycline. The sustained and spontaneous atrial arrhythmias, an unusual if not unique phenotype in mice, enabled initial explorations of mechanisms of AF using in vivo (telemetry), ex vivo (optical voltage mapping), and in vitro (cellular electrophysiology) techniques. We now propose to use this mouse model to more fully characterize the molecular mechanisms of arrhythmogenesis, to explore whether altered Ca2+ homeostasis contributes to the genesis and maintenance of AF, and whether targeting altered Ca2+ homeostasis could be an effective treatment of AF. Three Aims are proposed: Aim 1: To examine the downstream mechanisms by which increased cytosolic Ca2+ increases the propensity of AF. We will test using genetic and pharmacological approaches whether inhibitors of Na+-Ca2+ exchanger (NCX) and Ca2+-calmodulin dependent kinase (CaMKII) can inhibit AF in vivo and and spiral waves/rotors ex vivo. Aim 2: To test the causal link between increased persistent Na+ current, “leaky” RyR2, and the susceptibility for AF. We will use pharmacological and genetic approaches to inhibit RyR2 leak to see whether it plays a role in AF and whether it may be a novel therapeutic target. Aim 3: To test the causal link between mitochondrial dysfunction due to increased persistent Na+ current and leaky RyR2 channels, and the susceptibility for AF. The proposed studies may identify important links between dysfunctional Na+ channels, abnormal SR Ca2+ release in AF, defective Ca2+-dependent signaling in AF, mitochondrial dysfunction and oxidative overload in AF. Our studies are designed to provide rigorous and robust hypothesis-testing to open new understandings of the molecular bases of AF and to pave the way towards novel, mechanism-based, effective and safe treatments.

Public health relevance
Treatments for atrial fibrillation, which affects ~6% of Americans who are 65 years of age and older, are limited by the suboptimal efficacy and toxicities of pharmaceuticals and radiofrequency ablation/surgery, and high rates of recurrence. We have created a mouse model of atrial fibrillation that mimics human disease, and that now can be used to identify the molecular mechanisms of atrial fibrillation. Thus, the proposed research is relevant to public health and to the NIH mission to discover basic mechanisms underlying human disease.